Epigenetic modifications associated with intrauterine exposure to maternal type 2 diabetes.

Individuals exposed to maternal diabetes in utero are more likely to develop metabolic and cardiovascular diseases later in life. This may be partially attributable to epigenetic regulation of gene expression. To examine whether differential DNA methylation, a major source of epigenetic regulation, can be observed in offspring of mothers with type 2 diabetes (OMD) during the pregnancy as compared to offspring of mothers with no type 2 diabetes(OMND) during the pregnancy, we performed an epigenome-wide association study. A total of 423,311 cytosine-phosphate-guanine (CpG) sites were analyzed in 388 Native Americans, of which 187 were OMD and 201 were OMND. Forty-eight differentially methylated CpG sites (with empirical false discovery rate < 0.05), mapping to 29 genes and 10 intergenic regions, were identified. The gene with the strongest evidence was LHX3, where 6 CpG sites were hyper-methylated in OMD (P 1.1 10-5). Similarly, a CpG near PRDM16 was hyper-methylated in OMD (1.1% higher, P = 5.6 10-7), where hyper-methylation also predicted future diabetes risk (hazard ratio = 2.12, P = 9.7 10-5). Hyper-methylation near AK3L1 and hypo-methylation at PCDHGA4 and STC1 associated with exposure to diabetes in utero and decreased insulin secretory function among offspring with normal glucose tolerance. Analysis of all 29 genes in aggregate did not shown enrichment for any biologic pathway; however, literature searches provided evidences that several of these genes have a role in embryonic development and/or beta cell function. We conclude that intrauterine exposure to diabetes can affect methylation at multiple genomic sites. Methylation status at some of these sites can impair insulin secretion, increase body weight and increase risk of type 2 diabetes.

We have also conducted a genome-wide analysis to identify CpG sites at which methylation associates with BMI in Pima Indians. DNA methylation in 399 peripheral blood leukocyte samples was measured on the Illumina Infinium HumanMethylation450 BeadChip, and 423,311 CpG sites were analyzed. Each subject's BMI (measured at the time of blood sampling) was natural logarithm transformed and tested for association with DNA methylation with adjustments for appropriate covariates. CpG sites that achieved genome-wide significance in the discovery cohort (FDR p 0.05) were analyzed for replication in two existing datasets of Pima Indians (N = 320, age = 35; N = 183, age = 53). Among 263 CpG sites that associated with BMI in the discovery cohort, 9 replicated (p 0.05 and consistent direction of effect) in both replication cohorts. These were located in 6 genes and 2 enhancer elements. Three of these CpG sites map to genes (AHRR, RPS6KA2 and LGALS3BP) where DNA methylation has previously been reported to associate with BMI in other populations. The epigenetic associations at the remaining genes (DUSP5, RRAS2, APOBR) and enhancer elements are novel. Several of these genes have known roles in inflammation (DUSP5, LGALS3BP, APOBR, RPS6KA2) or cell proliferation (RRAS2 and AHRR). Thus, the present study has validated that DNA methylation at some genes associates with obesity in different ethnic groups, and it identifies other genes that may have a larger effect in American Indians.

Maternal obesity increases the risk for complications during pregnancy and early life of the infant. Independent of maternal obesity, gestational weight gain (GWG) is also a major determinant of maternal and fetal health. Excess energy during pregnancy is typically stored as fat mass, but it remains unknown how a sudden increase in maternal fat mass conveys an effect on the developing fetus. One possibility is that it exerts its effect through epigenetic mechanisms. In the near future, we plan to search for possible epigenetic changes in blood from individuals with measures of gestational weight. The identification of epigenetic marks associated with gestational weight gain may allow us to distinguish biological pathways that are regulated. Understanding the pathways that are affected could implicate the direction of future health in the mother and offspring.

In the near future we plan to obtain placental tissue from siblings (same mother). Placenta DNA will be isolated and analyzed for methylation. The infants will be followed for 18 years for measures of metabolic health, and we will determine whether placental methylation patterns predict future health outcomes in siblings.